CHOLESTEROL-RICH DIET AND PLASMA LIPID TRANSPORT

The objective of this study is to gain an understanding of the fundamental mechanisms determining the adaptive response of the plasma lipid transport system to excess dietary cholesterol.